Molecular basis for CRISPR-associated transposons and RNA-guided transcriptional regulation

Project Summary
Our research is dedicated to elucidating the molecular mechanisms of RNA-guided biological
systems, with a focus on CRISPR-associated transposons (CASTs) and emerging RNA-guided
gene regulation functions. Leveraging our expertise in single-particle cryo-electron microscopy
and a broad array of biochemical and functional assays, we aim to dissect the complex
interactions and structural dynamics in these natural systems. Our recent work has advanced
our understanding of diverse CRISPR-Cas systems, highlighting the structural basis for target
recognition and enzyme activation. We have also made progress in studying the assembly of
transpososomes that facilitate DNA transposition within CASTs.
The proposed research will explore the molecular basis underlying targeted DNA insertion by
CASTs, using Type I-B systems as model systems. Key questions include the structural
dynamics of transpososome assembly, the mechanism of directional DNA insertion, the role of
ATP hydrolysis in transposition, and a detailed understanding of target specificity. The insights
gained will inform the rational design of simpler, more efficient systems. Additionally, we will
investigate the structural basis of emerging RNA-guided gene regulation functions, which hold
potential for developing programmable gene regulation tools. Supported by the flexibility of the
MIRA mechanism, our goal is to deepen our understanding of RNA-guided systems, thereby
driving the development of next-generation genome editing tools and expanding their potential
applications in both therapeutic and basic research contexts.

Public health relevance
Project Narrative RNA-guided biological systems, such as CRISPR-Cas, can be easily tailored to target any sequence in the genome, making them valuable tools in both research and medicine. Our research seeks to understand how RNA-guided systems, especially those involved in DNA insertion and gene regulation, function at a molecular level. Our work is poised to unlock their full potential, contributing to further advances in biotechnology and genome editing.